52nd Annual Meeting of the American Aging Association: Integrative Approaches to Geroscience

Abstract.
We are requesting funds to support the 52nd Annual Meeting of the American Aging Association (AGE) that will
take place on June 2-5, 2024 in Madison, WI. The 52nd Annual AGE Meeting will be held in conjunction with the
Nathan Shock Centers of Excellence in the Basic Biology of Aging Symposium (June 2). Since its first
conference in 1971, the American Aging Association has been the only scientific society in the United States
focused solely on the biology of aging. The annual AGE meeting is one of the premier meetings in
biogerontological research and serves as a critical mechanism by which AGE advances its mission to promote
biomedical aging studies that target increasing the functional life span of humans, to keep the public informed
on these activities, to increase knowledge of biogerontology among health care professionals, and to foster the
scientific and professional career development of AGE trainees and scientific members. The primary goal of the
conference is to convene senior and junior scientists in a forum where the latest discoveries in aging research
are discussed and debated, to highlight exciting new research in the field, and to promote the emergence of new
ideas and collaborative activities among participants. The theme for the AGE 52nd annual meeting is “Integrative
approaches to geroscience”. The invited speakers include prominent established scientists, early career
investigators, and trainees, all of whom will be selected based on the quality and impact of their science. We
have planned 9 non-competing oral sessions that will be held along with three special lectures and a panel
discussion. Fostering the next generation of biogerontologists is a primary goal of the society; therefore, one of
the sessions will be organized in its entirety by the Trainee Chapter of AGE. In addition, we have chosen to have
at least two speakers in each of the sessions as early career investigators or trainees selected from submitted
abstracts. Two poster sessions are planned that will not compete with oral presentations. Abstracts will be
reviewed and scored and the top 40 poster presenters will be given the opportunity to present their posters in a
two-minute oral “poster pitch” during the regular sessions. Gender parity will be achieved, with women
representing 53% of invited and confirmed speakers, and 63% of symposium speakers being early career
researchers; at least 20% of speakers are from underrepresented groups. We expect that the meeting will be
held in person with a live-streamed virtual component. AGE has experience with both fully virtual and hybrid
meetings. We will adhere to established meeting guidelines, including ensuring that day care opportunities and
special need access are provided.

Public health relevance
Project narrative The annual meeting of the American Aging Association (AGE) is one of the leading annual conferences in aging research in the US, and advances AGE’s mission of promoting biomedical research towards increasing the functional life span of humans, increasing knowledge of biogerontology among the public and among health professionals, and fostering the career development of trainees and scientific members. The goal of the annual AGE meeting is to convene senior and junior scientists to discuss the latest discoveries in aging research, highlight new directions in the field, and promote the emergence of new ideas and collaborative activities among participants. We seek funding for the 52nd annual AGE meeting, where approximately 63% of all invited session speakers will be early career investigators or trainees, more than half will be women, and we will highlight participation from underrepresented minority groups.